Cancer Aging and Metabolism research experience Program (CAMP)

SUMMARY The Beckman Research Institute of City of Hope (COH) is a world-class cancer research institution
and cancer hospital with a mission of turning science into practical benefit through exquisite care, innovative
research, and vital education focused on eliminating cancer and diabetes. Increases in cancer incidence and
rising treatment costs highlight a need to advance cancer research through the growth of a diverse, well-trained
workforce. We propose an institution-wide, 10-week research experience for undergraduates focused on cancer,
aging, and metabolism, called the Cancer Aging and Metabolism research experience Program (CAMP). The
CAMP R25 is committed to training future scientific leaders who have the skills to develop novel technologies
and translate them into the clinic. CAMP will provide a focused, mentored research experience by matching
undergraduate trainees (CAMPers) with mentor-researchers from three thematic areas: Cancer Aging, Cancer
Metabolism, and Clinical Research. Each summer, CAMP will enable 20 CAMPers, selected via local and
nationwide searches, to participate in research that spans the arc of cancer research, from basic to bedside.
CAMPers will select from among 30 experienced COH Mentors who have a track record of mentoring students
with diverse interests and backgrounds. Principles of responsible conduct of research and rigor and
reproducibility will be taught by faculty. Hands-on laboratory research and auxiliary activities will be enhanced
by journal clubs, distinguished speaker seminars, and weekly CAMPer research presentations, as well as an
end-of-summer poster session. In addition, to address local community needs, and to bolster the pipeline for
undergraduates to thrive as future cancer researchers, we will also pilot a school-year program in which five
spots will be reserved yearly for motivated STEM students from a nearby, regional comprehensive public
university: California State University, Dominguez Hills (CSUDH), a minority-serving institution. Faculty from
COH and CSUDH have collaborated to design this program to extend the summer CAMP experience into the
academic year. The CAMP administrative structure includes highly qualified Directors and an Associate Director,
Internal and External Advisory Committees, and Recruitment/Admission, Curriculum Development, and
Assessment/Tracking Committees. This request for funding is justified by our long record of hosting successful
and creative summer programs that include local students from disadvantaged groups, the relevance of our
training experience to cancer research, the experience of our Mentors, the outstanding commitment of COH to
training, an authentic partnership between regional institutions, and the presence of a specific gap in federal
funding for undergraduates in the training continuum that spans elementary school to postgraduate education.

Public health relevance
Almost all human cancers have alterations in metabolic pathways associated with aging and cancer signaling, but undergraduates rarely receive cross-training in cancer metabolism and aging research. The proposed Cancer Aging and Metabolism research experience Program (CAMP) will address the need for a well-trained workforce by providing a unique 10-week hands-on learning experience for 25 undergraduates each summer. CAMP recruits from universities across the United States and bolsters a cancer research training pipeline with skilled trainees.